Quantitative Expression and Inter-Individual Variability of Skin Proteins Involved in Drug and Excipient Metabolism and Transporters Using Targeted and Label Free LC MS/MS Proteomics

Project summary
There are only few genetic alternatives for complex drug products such as the dermal
formulations. This is because establishing bioequivalence (BE) for dermatological drug
products by conducting comparative clinical endpoint studies can be costly and the studies
may not be sufficiently sensitive to detect certain formulation differences (Tsakalozou et al
2021). Establishing in silico models such as physiologically-based pharmacokinetic (PBPK)
might help with creation of alternative BE path without heavy reliance on large human
clinical studies. However, robustness of such PBPK models and their advantages for
answering the regulatory questions relay of sufficiency of system (non-drug-related)
information supplied to them. The interaction of drug and formulation ingredients with the
constituents of the skin (such as enzymes and proteins) determines the fate of the drug and
exertion of its therapeutic effects. These might be highly non-linear and they may vary
depending on the condition of the skin (health/disease) as well as location in the body and
the attributes of the population (age, ethnicity etc). In this project, the principal enzymes
and transporters of the human skin, which are relevant to both active moiety of dermal
products as well as the ingredients in the formulation, will be quantified using variety of high
resolution tandem mass spectrometry based proteomics measurements. This will be
achieved by a collaboration between academia, industry and the FDA and will address the
ongoing interest in providing robust in silico models for transdermal drug delivery systems.
These data are necessary for populating physiologically based pharmacokinetic (PBPK)
models of drug metabolism and disposition (including but not limited to those housed by
the Simcyp Simulator) of human skin. The aim is to achieve very broad coverage of relevant
proteins and, to this end, a global proteomic approach will be adopted. Proteomic studies
are labour intensive and the current published data on skin is limited to few samples. We
increase this to over 100 and attempt to stratify based on various attributes. In particular we
will address potential ethnic differences focussing initially on Caucasian population and
African-Caribbean individuals. All data will be used to populate the Simcyp MechaDema
PBPK model in first instance to create an immediate path for practical use by pharmaceutical
scientists however the data will remain open for all modellers engaged with PBPK.

Public health relevance
Project narrative The project will generate the most comprehensive quantitative data set of xenobiotics metabolizing enzymes and transporters in human skin with indication of attributes defining population variability (e.g. race, sex, age). The information is essential for building robust models of dermal drug absorption and for understanding the influence of formulation ingredients (e.g. excipients, vehicle) with implication for developing faster and safer new complex generic dermal products. The data will be incorporated into the structure of physiologically based pharmacokinetic software (MechDermA PBPK, Simcyp) as proof of concept and will be used for predicting dermal absorption based on in vitro data under the newly established framework of virtual clinical trials in diverse population of patients.